A Novel Anti-inflammatoryand Anti-oxidant Therapy for Treating Non-healing Diabetic Foot Ulcers

SUMMARY
Delayed or impaired wound healing is a serious complication of diabetes, often leading to lower limb
amputations. By 2050, 1 in 3 Americans will develop diabetes, and up to 34% of diabetic patients will develop a
diabetic foot ulcer (DFU) in their lifetime. Current treatments for DFUs include debridement, infection control,
maintaining a moist wound environment, and pressure offloading. Despite these interventions, a large number
of DFUs fail to heal and are associated with a cost that exceeds $31 billion annually. Chronic inflammation and
increased oxidative stress have been implicated in the pathogenesis of the diabetic wound healing impairment.
We have designed and tested a new therapeutic that synergistically targets both inflammation and oxidative
stress using novel cerium oxide nanoparticles (CNP), which possess reactive oxygen species (ROS) scavenging
properties, conjugated with an anti-inflammatory microRNA mimic (miR146a) that is deficient in diabetic wounds
and inhibits the activation of NFκB-induced pro-inflammatory response. Importantly, our novel patented
conjugate CNP-miR146a efficiently delivers miR146a into the wound to reduce inflammation and ROS, and
accelerate wound healing.
We have developed a CNP-miR146a specifically formulated for intradermal injection (CTX-001) for the
treatment of DFUs. Our preliminary studies demonstrate that a one-time intradermal administration of CTX-001
to full-thickness wounds fully corrects the wound healing impairment in diabetic mice and elicits a significant 25%
improvement in wounds in diabetic pigs, essentially by normalization of inflammation and oxidative stress.
Repeated weekly administration can correct the diabetic wound healing impairment, similar to healing in non-
diabetic wounds. Following a Pre-IND meeting with the FDA and having completed a pilot bulk drug substance
cGMP manufacturing of CTX-001, the objective of this Direct to Phase II application by Ceria Therapeutics
(Ceria) is to complete cGMP-grade manufacturing and analysis of CTX-001 drug product (Specific Aim 1) to fulfill
IND-enabling studies. Specific Aim 2 will confirm the preclinical efficacy of CTX-001 in diabetic (Db/Db) mice and
a porcine model of diabetic wound healing; we will assess the role of infection on the efficacy of CTX-001 in
mice, and optimize the dose and frequency of administration of CTX-001 to enhance efficacy in the correction of
the impaired healing in diabetic pigs. In Specific Aim 3, we will carry out a dose-range finding acute toxicity study
of CTX-001 in both rats and minipigs, followed by IND-enabling repeat dose toxicology studies. In vitro
genotoxicity studies and an irritation/sensitization study in guinea pigs will complete safety studies in preparation
for First-in-Human clinical trials with our lead product.

Public health relevance
NARRATIVE Non-healing wounds in diabetic patients represent a significant clinical problem and effective treatments are lacking; only one therapy is currently approved by the FDA, but exhibits questionable efficacy and is less effective than our product, CTX-001. CTX-001 has been formulated as an injectable gel to target two critical events that are dysregulated in diabetic wounds: chronic inflammation and oxidative stress. Based on strong preliminary data and our pre-IND meeting with the FDA, the ultimate goal of this Direct to Phase II proposal by Ceria is to complete cGMP-grade manufacturing and characterization of CTX-001 drug product, confirm efficacy in two relevant models of diabetic mice and pigs, and perform GLP-compliant toxicity studies to fulfill IND requirements.